Development of protein-based nanostructures activated by ultrasound

Project Summary / Abstract
The development of site specific nucleases for precise gene engineering has advanced basic understanding of
genes and their connection to phenotype-causing mutations and physiologically relevant endpoints and
treatment strategies to cure human diseases and medical disorders. It is critically important to mention that the
safe and efficient delivery approaches ensure the utilization of these programmable nucleases, thereby
improving the therapeutic potential of gene therapy. There are some terrific delivery systems and vesicles that
include viruses and viral captives that take advantages of their ability to target particular cell types. Nanoparticles
such as lipid nanoparticles, peptide nanoparticles, and gold nanoparticles can allow encapsulation of the
molecules for the delivery. However, still clever ways to try to address challenges in delivery of molecules are
required. We propose a revolutionary approach to realize controlled delivery of Cas9-ribonucleoprotein
(RNP). Our long-term goal is to develop a platform for delivering various types of macromolecules efficiently,
effectively, and safely for cell engineering in vitro and in vivo. The goal of this project is to develop a gas
vesicle (GV) and ultrasound based delivery approach (GVUS) to improve cell viability and cargo delivery
efficiency by conjugating GVs and purified RNP and monomeric streptavidin fusion protein (RNP-mSA-bioGV) to
form protein clouds for precise delivery using optimized ultrasound excitations after the investigation of
ultrasound parameters to induce stable oscillations and cavitation of GVs. GVs are biocompatible and intact for a
long time due to their stability while immediate clearance is available upon brief sonication. Stable oscillations
and cavitation of GVs under ultrasound excitation will be used for controlled disruption of cell plasma membrane
for intracellular delivery. In specific aim 1, we will investigate GV dynamics under different ultrasound excitations
and find optimized ultrasound parameters to generate stable oscillations and cavitation of GVs. We will test
various delivery modes using optimized parameters. We will develop RNP-mSA-bioGV protein clouds for
controlled delivery of RNP for gene editing, followed by the characterization of the protein clouds in specific aim
2. Primary mouse T cells will be engineered using developed protein clouds delivered by GVUS to study gene
editing precision and in vitro anti-tumor activities of engineered T cells to assess the feasibility of the proposed
approach in specific aim 3. An innovative approach to use protein clouds controlled by ultrasound will
revolutionize the current delivery techniques to engineer cells for research in laboratories and clinical
applications. Although many cell therapies have significant challenges in manufacturing and cost, we expect that
GVUS approach combined with protein clouds will contribute to realize simpler and cheaper patient-specific and
cell-based therapy.

Public health relevance
Project Narrative Gene cargo delivery systems remain the major challenges to advance cell-based and patient-specific therapies. The goal of the proposed study is to develop an in vitro non-viral intracellular delivery approach for effective gene engineering by combining gas vesicles, protein shells containing gas in the core, and Cas9- ribonucleoprotein (RNP) to form protein clouds as delivery cargo, controlled by ultrasound excitation for safe and efficient manipulation of target cells. The proposed approach has the potential to provide advanced genetic modifications that are required to treat advanced diseases such as solid tumor immunotherapy and neurodegenerative diseases.